Surgical pathology-enabled augmented reality for head and neck tumor resection with deformation modeling

Project Summary
The importance of achieving a clear margin in head and neck surgery is emphasized by the fact that a positive
margin status increases all-cause mortality by 90%. Yet positive margin rates in oral cavity cancers are among
the highest of solid malignancies and have not improved in the past two decades. Of the 65,000 cases each year,
up to 78% will undergo surgical treatment. Surgical treatment generally involves lump resection of the tumor with
a margin. After initial resection, the resected specimen is sent to pathology to analyze margins through frozen
section analysis. Due to the importance of clear margins, the current standard of care is to re-resect if there is a
close or positive margin. Unfortunately, studies have found surgeons to be 10.3-20.6 mm off in relocating margin
and additional cancer is only found in 20-30% of the cases. Patients with initial positive margins re-resected to
negative margins have local recurrence rates similar to those of patients with ﬁnal positive margins.
To improve re-resection success, we propose an augmented reality (AR) guidance system with deformation
modeling to aid the relocation task. Once the surgeon completes the initial resection, we 3D scan the resected
specimen to create a mesh of the tumor. An RGBD camera mounted above the patient will additionally capture
a 3D point cloud of the resection bed. Using the resection bed point cloud as the target, the 3D scanned mesh
will be deformed to match. The deformation will be driven by our previously proposed linear iterative boundary
reconstruction models. Additionally, we will extend the models to account for additional mechanisms that drive
deformation in head and neck specimens and develop novel methods to quantify uncertainty in the deformed
mesh. This mesh will be uploaded to an AR system so that a projection of the deformed specimen with pathology
annotations appears on the resection bed to aid relocation. To ensure clinical translation, we will conduct co-
design studies with surgeons and surgical trainees to discover what features they consider important for such
a guidance system. The interviews will be coded and feedback will be used to reﬁne the AR interface. This
proposal will be evaluated based on two phases. In the ﬁrst, surgeons with little AR guidance system experience
will be asked to resect and relocate margins on phantoms that experience no deformation to test how well the
AR interface aids relocation. In the second phase, a surgeon with extensive experience with our AR guidance
system will perform resection and margin relocation in cadavers that experience deformation. This phase tests
how well the deformation model aids relocalization. Together, these two phases represent the upper bound of
how well the proposed system can aid margin relocation.
The endpoint of this R01 will be 1) a deformation model for head and neck tumor specimens and 2) a validated
AR guidance system to guide re-resection. This study will generate the necessary experimental data to power
clinical trials in patients to evaluate margin relocation. As our AR guidance system does not require integration
with operating room equipment, it could in principle adapted to beneﬁt other solid malignancies.

Public health relevance
Project Narrative Around 65,000 new cases of head and neck squamous cell carcinoma are diagnosed in the United States each year and the majority of these patients will undergo surgical resection during their treatment. Complete resection of the cancer with clear margins is the goal, but positive margin rates in oral cavity cancer patients are among the highest among all solid malignancies. This project aims to develop an augmented reality and deformation modeling system to aid surgeons in achieving the complete removal of cancer.